SFSU/UCSF M.S. Bridges to the Doctorate Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This supplement supports the SFSU Bridges to the Doctorate program. The goal of the Bridges to the Doctorate Research Training Program at San Francisco State University (SFSU) (“Bridge Program”) is to develop a diverse pool of scientists earning a Ph.D., who have the skills to successfully transition into careers in the biomedical research workforce. SFSU and the University of California, San Francisco (UCSF) have developed a cooperative graduate program to increase the number of under-represented students that pursue biomedical research careers. This Program will provide students (primarily Biology and Biochemistry) with a quality and focused master's degree education at SFSU that prepares them to be competitive for acceptance into top-ranked biomedical science doctoral programs such as UCSF. The objectives are to: 1) engage all Bridge trainees in research activities, 2) provide the scientific literacy to ensure the successful completion of M.S. and Ph.D. degrees in a timely manner, and 3) ensure the transition of Bridge trainees to Ph.D. programs. These objectives will be successfully met through the combination of (i) close and careful academic and research advising by peers, preceptors, course instructors and PDs, (ii) a nurturing and productive research experience with Bridge preceptors, (iii) registration in two courses (“Strategies for Success” and “SCIP: Science Coding Immersion Program”) that provide professional development to improve computational, quantitative, writing, and oral communication skills while building community, and (iv) role modeling from established UR scientists in our formal Speaker Series. This supplement award aims to support establishing a broader institutional community for first-generation students from historically marginalized groups at research-intensive and industry partners. This initiative aims to strengthen the network of historically marginalized students at SF State interested in STEM fields. This project will enhance and expand our BE-STEM organization by including inter-institutional mentoring and community networks to support students pursuing careers in STEM research. This initiative aims to facilitate real-time mentoring across different institutions, enabling mentees to learn about the transitions between career stages.

Public health relevance
Enter the text here, which is the new public health relevant information for your application. Using no more than two or three sentences, describe the relevance of this research to public health. The NIH Bridges to the Doctorate Training Program at SFSU is a joint project between the Hispanic Serving Master’s institution, San Francisco State University (SFSU), and the pre-eminent PhD granting institution, the University of California San Francisco (UCSF). It prepares a diverse population of master’s students at SFSU to enter into top ranked biomedical Ph.D. degree programs such as UCSF, with the skills to successfully complete their Ph.D. degrees, en route to careers in the biomedical research workforce. The partnership between SFSU and UCSF addresses the need to diversify the scientific research community at the Ph.D. level.